Cerebellar Nuclei Dysfunction in Spinocerebellar Ataxia Type 1

PROJECT SUMMARY/ABSTRACT
SCA1 is a dominantly inherited neurodegenerative disease caused by expansion of CAG repeats in the
ATAXIN-1 (ATXN1) gene. Patients with SCA1 suffer from progressive gait and balance deficits, and severe
degeneration of Purkinje cells (PCs) in the cerebellar cortex and neurons in the cerebellar nuclei (CbN). There
are no effective disease modifying therapies currently available for SCA1, indicating a critical need for better
understanding of disease pathogenesis.
Cerebellar nuclei are a key part of the cerebellar network and the main information output from the cerebellum.
As a consequence, CbN are relevant to motor behaviors regulated by the cerebellum. Remarkably, very little is
known about the dysfunction of CbN in any of the spinocerebellar ataxias (SCAs), including SCA1. The
research described in this proposal will determine how CbN function is altered throughout SCA1 progression,
how mutant ATXN1 (mATXN1) impacts the CbN, and how changes in CbN contribute to SCA1-like motor
deficits. An additional impact of this study will be to expand the concept of SCA1 as a cerebellar circuit
dysfunction disease, stimulating future studies into interactions of the cerebellar cortex and CbN, not only in
SCA1, but in other ataxias as well.

Public health relevance
PROJECT NARRATIVE Cerebellar nuclei (CbN), the main output from the cerebellum, play the key role in the regulation of movement, and have well-demonstrated pathology in patients suffering from spinocerebellar ataxia type 1 (SCA1). Currently, very little is known about the disease pathogenesis in CbN in any of the spinocerebellar ataxias (SCAs), including SCA1. The research described in this proposal will fill these gaps in our knowledge by determining how function of CbN is altered throughout SCA1 progression, how changes in CbN contribute to SCA1-like motor deficits, and how mutant ATXN1 (mATXN1) impacts CbN in SCA1.